EVALUATION OF CARTILAGE GROWN FROM RIB PERICHONDRIUM

The long term failure rate of total joint replacement makes it an unsuitable selection for the treatment of arthritis in the young and middle aged patient. A more appropriate treatment for these patients is a procedure that restores the joint surfaces back to their normal state with biologically competent tissues. It has been demonstrated that rib perichondrium transplanted into a joint will proliferate to form a hyaline cartilage, and that this neocartilage continues to mature until it is almost identical to the tissue it is replacing. The objectives of this proposal are to develop and test a system of graft fixation wherein the perichondrium is secured to a bone plug utilizing a dacron mesh laid over the perichondrium. The composite dacron perichondrium/bone plug will be placed into the medial femoral condyle of the rabbit. The knee will be treated for 2 wks. with intermittent continuous passive motion. The regenerated neocartilage will be studied both short term (6-12 wks.) and long term (26, 52, 78 and 104 wks.) and will be evaluated using morphological, biochemical and biomechanical techniques. Normal articular cartilage will serve as a control. The goal is to achieve a clinical biologically acceptable result from perichondrial transplantation.